Determining the effects of pregnancy and aging on the mammary gland

PROJECT SUMMARY/ABSTRACT
The long-term goal of this proposal is to elucidate the molecular and cellular processes underlying breast cancer
risk reduction by an early full-term pregnancy. Specifically, the objective of this project is to determine the impact
of age and pregnancy on mammary epithelial cells (MECs). Preliminary analysis of bulk single-cell RNA
sequencing data from 18 month old nulliparous (no pregnancy) and 18 month old parous (at least 2 pregnancies)
reveals that pregnancy induces a persistent inflammatory and differentiated state in MECs. Intriguingly, luminal
MECs from aged, parous mice exhibit heightened inflammatory signaling but reduced proliferative capacity when
challenged with TNFα. I have also identified a minority population of Krt6a+ hybrid MECs that increase with age
but are lost in parous mice. Building on these exciting preliminary results, I hypothesize that an early pregnancy
alters the aging trajectory of stem/progenitor MECs to induce differentiation and inflammation programs that
reduce cellular plasticity and oncogenic vulnerability. Aim 1 will determine the impact of aging and pregnancy on
TNFα-mediated inflammatory responses and oncogenic vulnerability in MECs. Aim 1A will determine whether
Tnfrsf11b, an inhibitor of TNFα-induced apoptosis that is downregulated in aged, parous luminal cells, is
responsible for the restricted growth of TNFα-treated luminal organoids from aged, parous mice. Aim 1B further
explores whether the altered inflammatory profile in aged, parous MECs diminishes their tumor initiation capacity,
a critical factor in understanding breast cancer risk dynamics. Aim 2 addresses the roles of Krt6a+ hybrid MECs
in lineage plasticity and oncogenesis. Preliminary data show that Krt6a+ hybrid cells accumulate with age but
are lost by pregnancy. Recent studies highlight the importance of lineage plasticity as a precursor to tumor
initiation, providing a unique angle for understanding the dynamics of breast cancer protection. Aim 2A
investigates whether the pregnancy-induced reduction of Krt6a+ cells lessens tumor burden by inducing specific
mutations. Aim 2B explores the roles of unique Krt6a+ genes, Aldh3a1 and Il33, in maintaining a plastic cell state
through overexpression and knock-down assays. This approach aims to define the role of Krt6a+ progenitors in
pregnancy-induced protection in breast cancer, potentially serving as a future biomarker. In summary, this
project will address the significant gap in understanding how an early full-term pregnancy alters age-
induced senescence pathways in the mammary gland to ultimately reduce breast cancer risk. The
experiments will be conducted under the guidance of Dr. Shaheen Sikandar and with the exceptional resources
provided by UC Santa Cruz. This proposal not only has the potential to illuminate the dynamics of breast cancer
vulnerability, but the training opportunity also places me in a position to develop into a self-directed and
independent scientist.

Public health relevance
PROJECT NARRATIVE Aging increases breast cancer risk, with 1 in 8 women diagnosed in their lifetime, and early full-term pregnancy reduces this risk by 50%. This project aims to determine how early pregnancy alters aging-induced senescence pathways in the mammary gland, impacting stem/progenitor mammary epithelial cells. Through investigating the interplay between age, pregnancy, and oncogenesis, this project aims to provide insights into pregnancy-induced breast cancer protection, offering potential clinical strategies and novel biomarkers.